Using Peripheral Microglial Exosomes to predict brain inflammation in the human Parkinson’s brain

In this proposal, we will determine if we can use microglial extracellular vesicles (EV) that have been shed into
the cerebral spinal fluid (CSF) and serum to predict the microglial activation state in the Parkinson’s brain (PD).
Currently, a major obstacle in the field is that there are no established and validated methods to detect brain
inflammation in response to neurodegeneration during life. Microglia, the resident immune cell of the CNS
constantly patrol the brain, looking for signs of infection or inflammation caused by a host of immune stimulants.
The role of microglia is to clear potential threats to the CNS, but their chemical signatures based on their
presence are continuously released (cytokines). These cytokines activate neighboring microglia initiating a
cascade of events that are believed to drive disease pathogenesis. Although cytokines are generally considered
to function as soluble molecules, recent efforts have shown that cytokines are encapsulated in EVs. These EVs
contain a host of inflammatory-associated mRNAs that encode cytokine-associated genes among other signaling
molecules that are known to reflect the physiological state of the parent cell. Unlike microglia, EVs can cross
the blood-brain barrier under leaky and inflamed conditions, both of which are known physiological processes in
PD. To determine if we can identify microglial EVs in the periphery we will characterize EVs isolated from
disease-associated microglia (DAM) using RNAseq and Liquid chromatography-mass spectrometry (LC/MS).
This novel data will be used to generate targets for discovery work in the periphery. This proposal aims to address
two unmet needs 1) the possibility to detect brain inflammation in the living and 2) the ability to distinguish EVs
released from microglia from those released from peripheral blood mononuclear cells. We hypothesize that
microglial EVs extracted from the serum/CSF will reflect EV profiles from DAM. To test our hypothesis, we
propose to 1) Analyze membrane-bound proteins and EV cargo in disease-associated microglia (DAM), 2)
analyze membrane-bound proteins and EV cargo in peripheral EVs isolated from PD peripheral blood
mononuclear cells, 3) identify and validate unique microglial-specific EV membrane antigens for antibody
discovery work and 4) use these validated antibodies to pull down microglial-specific EVs from CSF and serum.
All the tissues proposed in the application were collected from premortem PD patients who have since passed
and have pathological confirmation of disease without comorbidities. We believe that each of these individual
aims is high impact, and novel on their own, but collectively could provide us the tools necessary to predict brain
inflammation.

Public health relevance
Neurodegenerative diseases progress over a long period of time before they become clinically apparent, and the physiological and molecular events which must ultimately be addressed to cure such diseases likely occur years before clinical diagnosis. The results from this data will provide the framework, and a potential therapeutic approach to identify one the earliest known factors in the progression of Parkinson’s disease, neuroinflammation.